New cryo-EM methods to visualize ribosome heterogeneity at single molecule resolution in cells

PROJECT SUMMARY
Cryogenic electron microscopy can generate atomic resolution views of cells and is therefore a promising
technology to study the molecular mechanisms underlying key cellular processes in cells. However, cryo-EM
images cannot be interpreted directly to atomic resolution because cryo-EM imaging introduces radiation
damage to biological macromolecules. Current strategies to address radiation damage require combining
multiple copies to generate a single 3D reconstruction representing an average of the individual molecules. This
not suitable for cellular imaging because only a select few macromolecules are present in sufficiently high
numbers to generate an interpretable average. As a postdoc I contributed to the development of an alternate,
single molecule strategy to characterize the structure, interactions, and organization of macromolecular
complexes in cryo-EM images called 2D template matching (2DTM). Since 2DTM does not require averaging, it
has the potential to simultaneously visualize all cellular complexes individually, presenting a potentially
revolutionary new understanding of cellular function in health and disease. However, the potential of 2DTM is
currently limited by the difficulty to localize smaller complexes. With support from the NIH New Innovators
Program, I will pursue new strategies to extend 2DTM to detect and characterize smaller structures. New
technologies, particularly new imaging technologies, open new avenues of research because they allow us to
ask questions and see things that were never previously possible. Opening the cell to visualization at the
resolution of individual macromolecules will undoubtably reveal new, previously unanticipated biology.

Public health relevance
PROEJCT NARRATIVE Cells are the fundamental unit of life. All cellular functions ultimately result from the structure, interactions, and organization of their component macromolecules. I will develop new methods using cryo-EM to visualize macromolecular structure within cells. This will provide previously inaccessible insight into the molecular mechanisms of cellular processes in health and disease.